Brain networks predicting variability in episodic memory quality

Project Summary
Episodic memory involves the construction of a complex mental representation that includes key features of an
event (i.e., its people, objects, and places) and their relationships with one another. This process has been
reliably associated with activity in a core network of posterior medial (PM) brain regions, including areas in
medial temporal, medial parietal, and lateral parietal cortex. Yet much remains unknown about how these brain
regions contribute to the specificity with which distinct event features are bound and recalled. Past
investigations of memory specificity have largely focused on the contributions of individual brain regions, such
as the hippocampus and lateral parietal cortex. However, recent evidence suggests that memory specificity
may be explained, in part, by functional interactions among brain regions, including those in the PM network.
The overarching goal of this proposal is to investigate the brain network interactions predicting the
multidimensional quality of episodic memory, focusing on how distinct event features are bound into memory
and the specificity with which they are represented. Our central hypothesis is that there are separable
pathways through the PM network that maintain the general relational structure and specific details of an
event, and that these pathways must interact to embed specific details into event memories. We will test this
hypothesis by leveraging the complementary strengths of functional magnetic resonance imaging (fMRI),
transcranial magnetic stimulation (TMS), and cognitive experimental design. First, we will examine variability in
memory binding and specificity across events, using analytic methods to predict memory quality based on
brain network interactions during encoding and retrieval (Aim 1). Second, we will test the causal role of PM
network interactions in episodic memory, using a combined TMS and fMRI design to identify post-stimulation
network changes and their impact on memory quality (Aim 2). Finally, we will investigate individual differences
in episodic memory quality, testing whether they can be explained by differences in PM network recruitment
and organization (Aim 3). The proposed research advances a novel framework for understanding the
interactive pathways supporting episodic memory, with the potential to significantly transform our
understanding of the brain mechanisms supporting memory for complex events. Furthermore, by building a
model linking episodic memory quality to specific patterns of network activity and communication, we will be
better equipped to understand the mechanisms underlying changes in memory binding and specificity often
associated with psychiatric and neurological disorders.

Public health relevance
Project Narrative The proposed project aims to investigate the brain network interactions supporting memory for the specific details of events. We will examine the network processes that contribute to the binding and specificity of event details, building a model explaining how these key aspects of memory quality vary across events and across individuals. Delineating these mechanisms will improve our ability to understand and intervene on qualitative memory changes associated with psychiatric and neurological disorders, such as reductions in memory specificity observed in affective disorders.